Feasibility of mHealth Technology for Improving Self-Management and Adherence Among Asthmatic Adolescents

Asthma self‐management is essential for preventing exacerbations and reducing the burden of the disease.
However, poor adherence to prescribed treatment and poor recognition of symptoms leads to reduced
asthma control, particularly among adolescents. Studies show that adolescents lack understanding about
self‐management, and that asthma education during clinic visits is deficient, resulting in insufficient asthma
management. Mobile technology, specifically, mobile applications (or apps) are an efficient way to increase
patient‐provider communication, provide feedback on asthma management, and deliver asthma education.
Our pilot work has demonstrated that an app can be effective at improving asthma control in adolescents aged
12‐17, and that adolescents are enthusiastic about utilizing mHealth technologies for asthma management, but
that existing apps are not engaging or appealing enough to an adolescent population to sustain long‐term
use. For this pilot study, we will test the feasibility, acceptability, and adherence to a smartphone app for
asthma self‐management in order to obtain data necessary to complete a future large efficacy trial of the app in
adolescents with persistent asthma. The objective of this project is to use an agile, iterative, user‐centered
design process to tailor our existing proof of concept app to adolescent user preferences and to use a mixed‐
methods approach to test feasibility, acceptability, adherence, and preliminary efficacy. The long‐term goal is
to identify mHealth technological approaches that facilitate self‐management of chronic diseases, particularly
among adolescents, and to develop marketing strategies to promote long‐term support of these approaches.
The rationale for this project is that adolescents are quick to adopt mobile technologies, have a high degree of
smartphone use, and are at a point of transition from parental management of their chronic condition to self‐
management, making this a priority population for the development of interventions targeting asthma control.
For this project, we have two specific aims: 1) To refine an asthma self‐management app for adolescents with
persistent asthma; and 2) To assess feasibility, acceptability, and adherence to the app in a small
randomized controlled trial. The approach is innovative because we are incorporating a user‐centered design
process to integrate multiple components for facilitating asthma self‐management in a mHealth tool tailored
for adolescents within the Technology Acceptance Model framework. Despite studies showing that mHealth
tools can be effective, few have prioritized an adolescent audience or evaluated the tool compared to standard
of care using rigorous, mixed‐method approaches. This research is significant because asthma is the most
common chronic disease of childhood in the US and the prevalence of the condition continues to rise, and so
innovative tools to improve self‐management of the disease are critically needed.

Public health relevance
Asthma is the most common chronic disease in childhood, which makes the proposed research a significant public health burden. This pilot is designed to test the feasibility, acceptability, and adherence to a smartphone app for asthma self-management among adolescents with persistent asthma. Knowledge gained from this pilot study will be used to design and conduct a future efficacy trial of the app. This project addresses the mission of NHLBI by developing a novel intervention to treat asthma. This study leverages our formative and pilot work to continue making strides towards enhancing asthma control among adolescents with persistent asthma in order to reduce asthma-related morbidity.